Smad4 is a master regulator for extracellular matrix homeostasis in the corneal stroma

PROJECT SUMMARY/ABSTRACT___________________________________________________________
Transforming growth factor-beta (TGF-β) is one of the most important growth factors involved in
morphogenesis of ocular anterior segment tissues including corneal stroma, a transparent tissue layer
responsible for acquiring normal vision. To elucidate the role of TGF-β signaling pathway in the corneal
stroma, we discovered that TGF- β receptor 1 (Tbr1) and Smad4 knockout (KO) mice showed bilateral corneal
stroma thinning phenotype, but the phenotypic manifestations between them were distinct. Smad4 KO
exhibited nonprogressive and uniform corneal thinning from limbus to limbus; however, Tbr1 KO mice
displayed progressive and irregular/uneven corneal thinning. Interestingly, the more severe corneal thinning in
Tbr1 KO mice can be rescued by simultaneously deleting the Smad4 in Tbr1/Smad4 double knockout (DKO)
mice. In other words, the phenotypic manifestation of the Tbr1/Smad4 DKO recapitulated Smad4 KO but not
the Tbr1 KO phenotype. Because corneal stromal morphogenesis and homeostasis rely on the balance
between ECM synthesis and degradation, we hypothesize that Smad4 not only plays a pivotal role in the
Tbr1-dependent ECM synthesis pathway but also participates in the Alk1/Smad1,5-dependent ECM
degradation pathway. This makes the Smad4 a key regulator that controls ECM synthesis and ECM
degradation in the corneal stroma. We propose the following Specific Aims to establish an equivalent role of
Smad4 in Tbr1-independent and Alk1/Smad1,5-dependent ECM degradation pathway which is critical for
corneal stromal morphogenesis and homeostasis.
Specific Aim 1: . Rescue of the progressively stromal thinning phenotype of Tbr1 KO by targeting
components of Alk1/Smad1,5/Smad4 axis through gene knockout or chemical inhibitors.
Specific Aim 2: To determine that Smad1, Smad5, and Smad4 have similar chromosome binding
profiles in Tbr1 KO keratocytes through genome-wide chromatin immunoprecipitation (ChIP) assays
with next- generation sequencing (NGS).
Impact: Completion of these proposed aims in two years will provide new knowledge regarding the critical
roles of Smad4 as a key regulator that controls both ECM synthesis and degradation for the corneal stromal
morphogenesis and maintenance of tissue homeostasis-serving as the basis for the long-term goal of
improving eye care and related ocular diseases like corneal ectasia.

Public health relevance
PROJECT NARRATIVE______________________________________________________________________ The overarching goal of this proposal is to elucidate the new role of Smad4 as a key regulator that controls extracellular matrix (ECM) synthesis and degradation for corneal stromal morphogenesis and maintenance of tissue homeostasis. In Tbr1 KO mice, excess ECM degradation results in progressive and irregular/uneven corneal stromal thinning, the hallmark of corneal ectasia (CE), which can be rescued by simultaneously deleting Smad4. Knowledge acquired from this study will provide insights into understanding the molecular pathogenesis of CE mouse models. Results from small chemical inhibitors to the ECM degradation pathway will facilitate future clinical trials once similar pathways can be confirmed in human CE.